Balancing epithelial cell resistance and resilience to respiratory viral infections

SUPPLEMENT PROJECT SUMMARY
Single-cell studies of the nasal mucosa of COVID-19 and influenza patients have helped to identify epithelial
cell subsets and states that are associated with disease severity. Our project’s goal is to determine the roles of
specific transcription factors in specifying the fates and functions of discrete nasal epithelial cell subsets. We
have prioritized these epithelial subsets, which appear to emerge from the goblet cell lineage, based on our
preliminary data that highlight how closely-related goblet cell subsets are significantly enriched or depleted as
targets of viral infection. Our central hypothesis is that the combined activation of two transcription factors will
specify goblet cells that are uniquely-protected from RNA viral infection. Aim 1 will determine the downstream
targets and gene regulatory networks induced by these transcriptional regulators, and Aim 2 will investigate the
role of these transcription factors in regulating antiviral immunity in goblet cells. Identifying the transcriptional
regulators of these goblet cells will allow for the generation of better ex vivo models to study their function, and
to potentially rebalance epithelial cells in vivo to better-protect the nasal mucosa from viral infection.

Public health relevance
SUPPLEMENT PROJECT NARRATIVE We have recently identified through our work in human COVID-19 several types of cells which either seem to be preferentially infected or protected by SARS-CoV-2. However, many of these cells have been poorly described and do not currently exist within models of the upper airway. It is of important public health relevance to future viral pandemics to understand the transcription factor code to help shift the balance from cells that are easily infected to those which are more protected.